RNA epigenetic modifications in SARS-CoV-2

Abstract
Post-transcriptional RNA modifications are widespread and regulates numerous biological processes including
RNA metabolism, protein translation, gene expression, and disease. Among the more than 180 types of RNA
modifications, N6-methyladenosine (m6A) and pseudouridine (Ψ) are the two most prevalent. The m6A
modification is catalyzed by the host RNA methyltransferase complex of METTL3 and METTL14. The Ψ
modification is converted from the nucleoside uridine (U) by the host pseudouridine synthases (PUSs). Despite
being discovered in the 1950s, the biological functions of the m6A and Ψ modifications in the context of virus
infection remain poorly understood. This project is built upon our recent development of high throughput
sequencing techniques that have enabled mapping of m6A and ψ sites at a single base resolution. Using these
techniques, we discovered that SARS-CoV-2 RNA isolated from well-differentiated primary human bronchial
epithelial (HBE) cultures that include their in vivo target cells is heavily modified with m6A and ψ. In addition, we
have found that depletion of several m6A and ψ writer proteins decreases SARS-CoV-2 replication in HBE
culture. These findings led to our hypothesis that SARS-CoV-2 acquires m6A and Ψ modifications in its RNA to
maximize virus replication. Thus, the goal of this project is to determine the mechanisms by which RNA m6A and
ψ modifications modulate SARS-CoV-2 replication, gene expression, innate and adaptive immunity, and
pathogenesis. In Aim 1, we will use a CRISP-Cas 9 technique to knock out host RNA m6A methyltransferases
and PUSs in HBE cultures to determine the role(s) of m6A and Ψ modifications in the SARS-CoV-2 life cycle.
We will also use knockout mice to examine the role(s) of m6A and Ψ modification in SARS-CoV-2 replication in
vivo. We will also identify the specific PUS enzyme(s) that catalyze pseudouridylation on SARS-CoV-2 RNA. In
Aim 2, we will mutate the m6A and/or ψ sites in the SARS-CoV-2 genomic RNA and use the reverse genetics
system to generate recombinant SARS-CoV-2 lacking m6A and/or ψ modification sites and use them to
determine the roles of m6A and ψ modifications on viral RNA metabolism, encapsidation, RNA replication, viral
protein translation, and innate immunity. In Aim 3, we will determine whether m6A and ψ modifications modulate
mucosal and adaptive immune responses of SARS-CoV-2 live attenuated vaccines (LAVs) and determine
whether LAVs lacking m6A and/or ψ are more immunogenic in golden Syrian hamsters. Upon completion of this
project, we expect to have unravelled the mechanisms by which m6A and Ψ modifications modulate the SARS-
CoV-2 replication cycle, leading to the development of novel and improved LAVs and therapies for COVID-19
that target these RNA modifications.

Public health relevance
PUBLIC HEALTH RELEVANCE: SARS-CoV-2, the causative agent of COVID-19, has led to tremendous damage to all aspects of our society. The goal of this project is to identify major RNA modifications (N6- methyladenosine and pseudouridine) in SARS-CoV-2 RNA and to determine their biological functions in SARS- CoV-2 replication, gene expression, innate and adaptive immunity, and viral pathogenesis. Understanding these fundamental questions will facilitate the development of novel vaccines and therapeutic agents by targeting RNA modifications.